An innovative approach to nonhuman primate management with RFID tracking.

ABSTRACT
An Innovative Approach to Nonhuman Primate Management with RFID Tracking
The Emory National Primate Research Center (EPC) maintains a specific pathogen free (SPF)
rhesus macaque breeding colony of approximately 2500 animals that supports a rich research
portfolio of over $55 million in nonhuman primate grants in FY22 alone. This large SPF rhesus
breeding colony is maintained in large indoor/ outdoor social groups at the EPC Field Station
and has been managed to increase production over the past 10 years to meet the high demand
for research assignments. The successful colony growth has placed pressure on personnel
resources to support the growing breeding colony. In an effort to streamline operations, save on
personnel expenses and enhance animal welfare, the EPC is proposing to implement a novel
RFID tracking tunnel system in the large breeding compounds to passively track individual
monkeys and perform census counts without disruption of the social groups. Integrating this
proposed RFID tracking system to replace the current manual census counts will significantly
improve operational efficiency and allow personnel time to focus on other breeding colony
management objectives resulting in increased production in the colony. This increased
production will support the research projects at the EPC as well as the national demand for
NHPs for research.

Public health relevance
NARRATIVE This R24 application seeks support to implement innovative RFID tracking tunnels to improve management of the SPF rhesus macaque breeding colony at the Emory National Primate Research Center. The RFID tracking tunnels will allow passive identification of individual animals that will streamline personnel effort for tracking animals and improve animal welfare by minimizing social group disruption thus leading to improved colony production in support of research.